MRI catheter design and fabrication

During the past year we have continued our work developing magnetic resonance imaging (MRI) compatible and visible devices to perform endoluminal interventional procedures that are planned to perform under MRI. We have nearly completed a human-grade MRI guidewire that provides both tip and shaft visibility and provides assurance of safety during operation. We have developed a rigorous Good Laboratory Practice animal testing program. We are preparing a regulatory submission to allow first-in-human testing in the upcoming year. We continue to work on radio frequency heating safety tests of interventional MRI devices. We currently work on to develop a new general protocols to test heating safety of active intravascular devices during real time MRI procedures We continue to develop novel prototypes of catheters and implants to treat valvular and congenital heart disease.